Ecology and Evolution of Breast Carcinogenesis

Abstract: In early breast carcinogenesis, neoplastic cells grow in multiple layers towards the lumens of ducts,
which subjects the periluminal cells to harsh conditions of low oxygen, low pH, and nutrient deprivation.
Adaptation to these harsh conditions is a pre-requisite for survival of incipient tumor cells. Adaptations are initially
acute and reversible, but eventually Darwinian selection results in cells with hardwired phenotypes. A prominent
example of this is aerobic glycolysis, or the Warburg Effect (WE), wherein cells are hard-wired to ferment
glucose, even in the presence of oxygen. Notably, a WE is highly correlated with a cancer’s metastatic potential
and poor outcome. Hence, a major question in carcinogenesis is: “What are the mechanisms by which a harsh
microenvironment eventually selects for hard-wired (heritable) phenotypes, such as a WE?”. Rather than simply
selection of pre-existing phenotypes, we contend that the microenvironment actively induces phenotypic diversity
through a systematic set of epigenetic and genetic alterations.
To address this question, we combine preliminary data from three different approaches that are all focused
on the eco-evolutionary dynamics occurring during carcinogenesis: In the first, we have subjected benign breast
cancer and epithelial cells to harsh conditions encountered in DCIS and have observed that the cells that survive
these selections exhibit a WE. We selected three clones and applied single cell RNA sequencing and single cell
ATAQ sequencing as well as whole exome sequencing to map the transcriptome, epigenome, and mutation
patterns of the selected clones compared to their parental normal cells. This will form the model system to be
analyzed throughout the current proposal. In the second line of investigation, we have documented the profound
epigenetic changes that occur during progression of multiple myeloma (MM) from pre-malignant to metabolically
active disease. We hypothesize that these observations in MM can provide a framework to predict and interpret
the changes that breast cancer cells undergo as they transition from a benign non-glycolytic to an aggressive
glycolytic state. In the third line of investigation, we have outlined a continuum starting with epigenetic changes
and show how these result in permanent mutational or chromosomal changes. This latter work provides a
framework with which to predict and interpret how microenvironment-induced epigenetic changes can eventually
lead to hardwired genetic changes that are observed in aggressive glycolytic breast cancer. By combining these
approaches, we propose to decipher the mechanisms whereby microenvironmental stress-induced genome
evolution results in hard-wired phenotypic adaptations, represented by a WE.
At the end this study, we expect to have a more complete and comprehensive understanding of the
environmentally-induced epigenetic and genetic changes that occur during carcinogenesis, and how these relate
to hard-wired phenotypic profiles, as exemplified by the Warburg Effect.

Public health relevance
Narrative This proposal tries to answer a major question in carcinogenesis: “How do harsh microenvironments select for hardwired metabolic phenotypes, such as Warburg Effect, leading to carcinogenesis”? Combining three high technology approaches of cancer evolutionary biology, mathematical modeling, and system biology, we propose to decipher the relationship between microenvironmental stress-induced genome evolution that results in hardwired phenotypic adaptation represented by a WE as an initiator of cancer. Solving this problem will have significance as it is a long-standing problem in cancer biology.